Fostering Caregiver Connections via Intentional Technology Pairing for Caregivers of Patients with Alzheimer's Disease and Other Types of Dementia

Project Summary/Abstract
Minnesota HealthSolutions Corporation proposes to collaborate with the Mayo Clinic to develop a unique matching
service for caregivers of persons living with dementia, such as Alzheimer’s disease, Lewy Body dementia and
Frontotemporal degeneration. Caregiving for persons with dementia is demanding and research has shown that it
negatively effects the physical and mental health of caregivers. There are currently limited resources available for
caregivers of persons with dementia, mostly limited to online resources and group support. Research from
behavioral health has demonstrated that peer to peer support is effective and leads to improved quality of life,
more engagement with services, improved health, and reduced hospitalizations. Minnesota HealthSolutions will
collaborate with researchers from the Mayo Clinic Alzheimer’s Disease Research Center to develop a unique
program for matching caregivers of persons with dementia to provide support to each other.

Public health relevance
Project Narrative The proposed project seeks to develop a program to support caregivers of persons with dementia. An estimated 5.7 million Americans had Alzeheimer’s disease (AD) in 2018. AD is the most common form of dementia and accounts for about 60 to 70% of dementia cases. Dementia primarily affects older adults although an estimated 200,000 individuals under the age of 65 have younger-onset AD. The amount of care that persons with dementia require is significant. It is estimated that 17.4 billion hours of unpaid care to persons with dementia were provided in 2011. Caregiving is demanding and research has shown that it negatively affects the physical and mental health of caregivers. Providing support to caregivers of persons with dementia may improve the quality of life and health of these highly significant caregivers.